Administrative Core

Administrative Core - Core A The Administrative Core will provide assistance to the 3 research projects and 3 scientific cores that comprise this research program. It will provide fiscal oversight, assist with regulatory requirements, schedule meetings, organize the visits ofthe Advisory Committee, and help in any other employment, financial, publication or adherence issues, as needed. The Core is staffed by two experienced and dedicated individuals who have worked with the investigators for many years. RELEVANCE (See instruclions): This Core will help with the coordination of all aspects of the research except the experimental work.